Effect of Necroptosis in Neurons on Neuroinflammation, Neuronal Function, and Cognition

Chronic, low-grade inflammation (inflammaging) is a hallmark of aging and a major risk factor for both
morbidity and mortality as well as being a major risk factor for a variety of age-related diseases, including
neurodegenerative diseases. Despite the link between inflammation, aging, and age-associated diseases, the
molecular mechanism(s) responsible for inflammaging is poorly understood. The objective of my current Merit
VA grant was to determine if necroptosis, a cell death pathway that induces inflammation, played a role in
inflammaging. We showed for the first time that necroptosis increased with age in various tissues including brain
and was associated with an increase in various markers of inflammation. Importantly, we found that globally
inhibiting/blocking necroptosis reduced markers of inflammation, which supported our original hypothesis.
Interestingly, we found that the age-related increase in markers of necroptosis in the brain occurred primarily in
neurons in the hippocampus and cortex even though there is little, if any loss of neurons. Thus, the activation of
necroptosis in neurons does not appear to result in neuronal death. The overall objective of the current proposal
is to determine the mechanism(s) by which neuronal activation of necroptosis can impact the aging brain without
leading to neuronal death. We hypothesize that the activation of necroptosis in neurons leads to neuronal
dysfunction and the release of necroptotic extracellular vesicles, which induce neuroinflammation when
phagocytosed by microglia and/or astrocytes. We will test this hypothesis using mouse models in which
necroptosis activation is blocked or induced specifically in neurons, e.g., Ripk3fl/fl and Mlklfl/fl mice crossed to
transgenic Slick-H Cre transgenic mice to produce Ripk3NeuKO or MlklNeuKO mice in which necroptosis is blocked
and crossing Ripk3- or Mlkl-knockin mice to SLICK-H Cre-transgenic mice to produce Ripk3NeuOE or MlklNeuOE
mice, which overexpress RIPK3 or MLKL specifically in neurons. Using old (24- to 26-months) Ripk3NeuKO,
MlklNeuKO, Ripk3NeuOE, and MlklNeuOE mice compared to adult (6-months) and old wild type (WT) mice, we will
conduct the first experiments on the impact of necroptosis activation in a specific cell type (in this case neurons)
on inflammation and the function of a cell in the absence of cell death.
Aim 1. To determine the role of neuronal necroptosis activation in neuroinflammation. The impact of
reducing or inducing the activation of necroptosis in neurons on neuroinflammation in old mice will be assessed
by measuring proinflammatory cytokines/chemokines and markers of neuroinflammation in various regions of
the brain. We predict that altering necroptosis specifically in neurons will in turn impact neuroinflammation.
Aim 2. To determine the mechanism of how neuronal necroptosis activation leads to
neuroinflammation. First, we will determine if blocking or inducing necroptosis activates specific populations of
microglia or astrocytes in the hippocampus using single-cell transcriptomics. Second, we will determine if altering
necroptosis activation in neurons leads to alterations in the ESCART-III pathway, which prevents the rupture of
the cell membrane by necroptosis. In addition, the levels of necroptotic EVs (containing MLKL and MLKL
oligomers) in the hippocampus will be measured in our mouse models. Third, we will determine if neuronal cell
cultures, in which necroptosis activation is induced, produce necroptotic EVs that are phagocytosed by cultures
of microglia, leading to the activation of microglia and the generation of proinflammatory cytokines/ chemokines.
Aim 3. To determine the role of neuronal necroptosis activation on neuronal function and cognition. The
effect of reducing or inducing neuronal necroptosis activation on neuronal function will be measured as calcium
dynamics and long-term potentiation in hippocampal slices and the transcriptome of hippocampal neurons.
Cognition (e.g., Morris water maze, Phenotyper, fear conditioning, novel object recognition) will be measured in
old Ripk3NeuKO, MlklNeuKO, Ripk3NeuOE, and MlklNeuOE mice and compared to adult and old WT mice.

Public health relevance
The demographics of the veteran population clearly demonstrate that illnesses afflicting the elderly are a major concern of the Department of Veterans Affairs. Currently, the number of veterans over 50 years of age represents over 70% of the total veteran population. Research has shown that chronic, low-grade inflammation increases dramatically with age and that inflammation is a major risk factor for a variety of age- related diseases that affect elderly veterans, especially neurogenerative diseases like Alzheimer's disease. The research in this application will study a novel mechanism involved in neuroinflammation: the activation of necroptosis specifically in neurons is proposed to induce the release of necroptotic extracellular vesicles from neurons that activate microglia and astrocytes leading to neuroinflammation, which results in neuronal dysfunction and reduced cognition. Data from this project has the potential of leading to new therapies to treat neurodegeneration and the loss of cognition that occurs with age in elderly veterans.